The Role of Corticostriatal Microcircuitry in Sensorimotor Integration

Project Summary
The processing of sensory stimuli is fundamental for the selection of appropriate actions during behavior and
learning, a process known as sensorimotor integration. The striatum, a key input center of the basal ganglia, is
involved in sensorimotor integration, and disruptions in striatal networks can lead to disorders such as
Parkinson’s, Huntington’s, Tourette’s syndrome, and autism spectrum disorder (ASD). In mice, sensations and
movements are represented in the brain by changes in neuronal activity in the primary sensory (S1) and motor
(M1) cortex respectively. Although S1 and M1 share overlapping projections to the dorsolateral striatum (DLS),
which has been heavily implicated in the formation of sensorimotor associations, the underlying circuit dynamics
of how activity from S1 and M1 is represented in the DLS during sensory-guided decision making is poorly
understood. Recent work in our lab has demonstrated that during a whisker-based sensorimotor integration
task, stimulation of M1 corticostriatal projections excites striatal spiny projection neurons (SPNs) and fast
spiking interneurons (FSIs) equally, and promotes behavioral responding to the task. In contrast, S1
corticostriatal stimulation produces stronger excitation of FSIs compared to SPNs, and suppresses behavioral
responding. These findings strongly suggest that the opposing effects of M1 and S1 corticostriatal stimulation on
sensory guided decision-making are due to differences in their connectivity to DLS SPNs and FSIs. This proposal
investigates the hypothesis that S1 and M1 corticostriatal projections facilitate sensorimotor integration through
differences in their connectivity to SPNs and FSIs in the DLS. A viral circuit mapping strategy along with single-
cell filling will be employed in aim 1 to determine the input anatomy of S1 and M1 onto DLS SPNs and FSIs. The
capacity for plasticity at these synapses will be assessed in aim 2 using a combination of optogenetic stimulation
and electrophysiology. The encoding of sensory and motor related features of a Go/NoGo whisker-based
decision-making task in DLS SPNs and FSIs will be assessed in aim 3 using chronic in-vivo 2-photon calcium
imaging.
This proposed fellowship will support a training environment that is in line with the goals of diversity in
the NIH. It provides excellent opportunities to utilize impactful professional relationships both inside and
outside the scientific community. Furthermore, it will provides technical training for a strong foundation in
neuroanatomy, neurophysiology, and in-vivo imaging. Together, the proposal herein has significant potential to
prepare one for a successful scientific career, as well as significantly impact our understanding of sensorimotor
integration in the striatum.

Public health relevance
Project Narrative The ability to integrate sensory information is critical for understanding context and selecting appropriate actions, and disruptions in this process can lead to problems in controlling our movements and making decisions. This fellowship aims to investigate how the primary sensory and motor areas of our brain influence activity in the striatum, a key brain nuclei involved in sensorimotor integration and decision making. The findings may reveal novel insights about corticostriatal processing of sensory information, and can impact the treatment of disorders related to movement and learning.